GROWTH HORMONE FUNCT. AND TREATMENT IN ONCOLOGY SURVIVORS WITH GROWTH FAILURE

This study intends to better define growth hormone physiology in oncology survivors. It will correlate these findings with treatment modalities and evaluate the effect of growth hormone treatment in these patients.